Synapses as Independent Computational Units in the Excitatory Pathways of the Retina

Project Summary/Abstract
Determining the computational units of a neuronal circuit is essential in understanding the function of the circuit
as a whole. In many circuits, subcellular compartmentalization allows synaptic boutons on the presynaptic side,
and dendrites, on the post-synaptic side, to functional independently. In sensory systems, functional
divergence allows enabled the representation of many features of a stimulus using a limited number of
neurons. The retina is an advantageous model system for studying synaptic mechanism of circuit motifs, like
functional divergence, because our advanced knowledge of cell types and circuit architecture in the retina
allows us to ask precise questions about connectivity and function in response to visual stimuli.
In the mouse retina, signals diverge from two cone types to ~15 bipolar cell (BC) types, and then to > 40 retinal
ganglion cell (RGC) types at the output level. Mechanisms for functional divergence are well established at the
first synapse in the retina, but much less is known about mechanisms at the second synapse, from BCs to
RGCs. My work will fill this gap by establishing a model system in which a single BC type diverges to provide
functionally distinct input to two different RGC types. The core hypothesis of this project is that different
synapses from the same BC can act as independent computational units, relaying different patterns of
glutamate release to their postsynaptic partners.
In Aim 1, we will obtain physiological evidence that these two RGC types share input from different synapses
on the same BCs. In Aim 2, we will measure the ultrastructure of the synapses with electron microscopy to
determine the role of postsynaptic RGC identity on the structure of the BC synapses. In Aim 3, we will
demonstrate functional compartmentalization within the BC terminal, first with an electrotonic modeling
approach, and then with experimental measurements of glutamate release.
The successful completion of this project will resolve the question of whether individual BCs can transmit
functionally distinct glutamate signals from different synapses. Confirmation of functional divergence at the
level of BC synapses will alter our picture of the computational structure of retinal circuits. Instead of
considering bipolar cells as the computational units of excitation, we will instead show that bipolar cell output
synapses can perform independent computations. This paradigm change will have important consequences for
models of retinal circuits, and it will open up new areas of study into the molecular determinants of subcellular
wiring specificity in development.

Public health relevance
Project Narrative The goal of our research is to discover the mechanisms of visual computation in the retina. This proposal studies a circuit in which a single neuron transmits two functionally distinct signals to downstream neurons from different synapses. The discovery that synapses, rather than neurons, are the independent computational units of the inner retina will have important implications for the models of retinal function used in retinal prosthetics. This research will also have impacts beyond the retina in revealing fundamental principles of neural circuit architecture and mechanism in line with the goals of the BRAIN initiative.